Investigation of the role of the G protein-coupled receptor FSHR-1 in multi-tissue control of neuromuscular signaling in normal and oxidative stress conditions

PROJECT SUMMARY/ABSTRACT
Oxidative damage is a key contributor to many neurological and neurodegenerative disorders characterized by
imbalances in synaptic transmission. Inter-tissue signaling is vital to stress-induced synaptic modulation in the
face of such damage but is not fully understood. My long-term goal is to determine the molecular mechanisms
controlling synaptic transmission in the presence and absence of oxidative stress. Recent work from my lab
and others identified roles for the conserved G protein-coupled receptor (GPCR) FSHR-1 in regulating
neuromuscular signaling and oxidative stress responses. FSHR-1 is the sole C. elegans homolog of a
vertebrate glycoprotein (GP) hormone receptor family that controls various physiological and stress responses;
misregulated signaling by these GP receptors is linked to neurological and neurodegenerative conditions, like
depression and Alzheimer’s Disease. My lab previously found fshr-1-deficient C. elegans have neuromuscular
defects exacerbated by oxidative stress. In the prior funding period, we showed FSHR-1 acts in the intestine,
and likely also in glia, to cause muscle excitation via effects on cholinergic motor neurons and identified
downstream effectors and GP ligands of intestinal FSHR-1. Yet, the inter-tissue mechanisms by which FSHR-1
regulates neuromuscular function from these distal tissues under normal or stress conditions are unknown.
The objective of this proposal is to determine how FSHR-1 controls signaling at the C. elegans neuromuscular
junction (NMJ) via activities in multiple cell types in differing oxidative stress conditions. My unpublished data
indicate the conserved secretion regulator, HID-1, and insulin-like peptides (ILPs), INS-31 and INS-35, are
required in the intestine for intestinal FSHR-1 to promote muscle excitation and also show FSHR-1 expression
in a subset of astrocyte-like glia. Although FSHR-1 is required to promote motility in physiological conditions
and in chronic oxidative stress, my data indicate FSHR-1 is needed to prevent motility under acute stress. My
central hypothesis is that FSHR-1 acts downstream of - and β-GPs or other ligands in the intestine to
promote intestinal ILP release via activity of the secretion regulator HID-1, and in IL socket (ILso) glia via other
inter-tissue signals, to differentially regulate muscle excitation in chronic and acute oxidative stress. Aim 1 will
use cell-specific gene expression/inhibition, fluorescence imaging, and behavior to define intestinal secretory
pathways involved in FSHR-1’s effects on the NMJ. Aim 2 will use these methods plus cell-specific ablation to
determine if and how FSHR-1 expressed in ILso glia regulates NMJ function. Aim 3 will use genetic epistasis
and biochemistry to identify FSHR-1 ligands relevant for its NMJ effects in response to oxidative stress. This
research is innovative in its plan to define multiple inter-tissue signaling pathways of a conserved GPCR that
regulates synaptic transmission in varying physiological conditions. It is significant in identifying novel intestinal
and glial roles for FSHR-1, which controls diverse biological processes across phylogeny, and thus may
facilitate future treatments for synaptic dysfunction and oxidative stress, key contributors to aging and disease.

Public health relevance
PROJECT NARRATIVE This project involves defining the inter-tissue signaling mechanisms by which the conserved glycoprotein receptor FSHR-1 acts in the intestine and in glial cells to regulate neuronal communication under physiological conditions and in response to oxidative stress. The proposed research is relevant to public health because misregulated neuronal signaling and oxidative damage occur during aging and in many neurological and neurodegenerative conditions, which are among the leading contributors to worldwide disease burden. By characterizing the intra- and inter-cellular pathways involved in this cross-tissue regulation of neuronal signaling and identifying FSHR-1 ligands that act in normal and stress contexts, this project will contribute vital information to the understanding of the molecular mechanisms governing coordinated, multi-tissue control of neuronal signaling and oxidative stress biology, directly serving the mission of the NIH to gather critical knowledge that will contribute to understanding basic biology and reducing human disease.